AADOCR Bloc Travel Grant

Modified Project Summary/Abstract Section
The American Association for Dental, Oral, and Craniofacial (AADOCR) Bloc Travel
Grant program aims to attract a cross section of dental, oral, and craniofacial
researchers at the early stages of their scientific careers, by providing travel and
meeting support to the most promising U.S. dental and PhD students, residents, and
postdoctoral fellows to attend the AADOCR Annual Meeting – the national multi-disciplinary scientific meeting featuring cutting-edge dental, oral, and craniofacial
research, innovations in clinical care, and state-of-the-art technology - to present their
own research, participate in career development programming, and network with
established scientists in the field. The significance and impact of scientific conferences
are enriched when contributions come from all areas of expertise. AADOCR is
committed to providing a welcoming environment for all. AADOCR plans to provide
travel support to U.S. dental and Ph.D. students, residents, and postdoctoral fellows
based on objective assessments of merit and achievement, and those not currently
receiving NIH funding. AADOCR is requesting support for the AADOCR Bloc Travel
Grant program for three years for U.S. students, residents, and postdoctoral fellows to
attend the AADOCR Annual Meeting & Exhibition scheduled in the following locales:
New Orleans, Louisiana (2024); New York, New York (2025), and San Diego, California
(2026). The objectives of the AADOCR Bloc Travel Grant program are: to provide
financial registration and travel support to enable students, residents, and post-doctoral
fellows to present their research in a welcoming public scientific forum; to expose U.S.
dental, oral, and craniofacial research students, residents, and post-doctoral fellows to
research conducted at institutions across the United States and globally, and to
enhance the opportunities for networking, collaboration, and cross-institution
mentorship; to provide support to encourage investigators at a very early stage of their
career to further pursue dental, oral, and craniofacial research as a long-term career;
and to provide a means by which U.S. dental, oral, and craniofacial research students,
residents, and postdoctoral fellows may obtain information on the most current
methodologies employed in the latest dental, oral, and craniofacial investigations.
Consistent with NIH Notice NOT-OD-25-090, the AADOCR does not add any DEI,
DEIA, or discriminatory equity ideology programming, in violation of Federal anti-discrimination laws, to the Annual Meeting scientific program.

Public health relevance
Modified Public Health Relevance Section Oral health outcomes vary considerably across different segments of the population. Cleft lip and palate remain a common birth defect, oropharyngeal cancer is rising in young adults –related to HPV, and we’ve yet to harness the true diagnostic value of salivary biomarkers or leverage the tremendous genomic medicine advances for oral health improvement. Dental caries remains one of the most common diseases of childhood, periodontal disease prevalence estimates have recently been revised upwards to nearly half the adult populations after a more thorough full-mouth exam methodology; and oral health consequences of the use of e-cigarettes remain largely unknown. We must have a well-trained, dental, oral, and craniofacial health research workforce to address these challenges, to serve as the catalyst to develop appropriate strategies and further the translation of dental, oral, and craniofacial research.